Functional and mechanistic studies of human-specific long noncoding RNAs using a humanized mouse model

We previously addressed the challenge of incomplete human liver lncRNA annotation by combining an isogenic humanized mouse model with Nanopore direct RNA sequencing. This approach enabled us to generate a de novo transcript-level annotation of human liver lncRNAs under diverse metabolic conditions, uncovering numerous novel transcripts and revealing many that are dynamically regulated by physiologically relevant stimuli. This resource established a foundation for investigating human liver lncRNAs in metabolic regulation. Building on this annotation, we developed a cross-species pipeline to identify functionally conserved lncRNA metabolic regulators (fcLMRs). Using the humanized liver model exposed to multiple feeding states and transcription factor activations, we identified syntenic human-mouse lncRNA pairs with conserved regulation under metabolic challenges. Correlation analyses of lncRNA–mRNA expression in humanized mice, followed by pathway enrichment, yielded 59 high-confidence fcLMRs associated with conserved metabolic pathways. These findings provide a powerful framework for prioritizing human lncRNAs with functional roles in metabolism and highlight candidates for future mechanistic studies.